Hormone Receptor Regulation of RNA Polymerase III

Project summary
Steroid receptors are a subset of nuclear receptor (NR) transcription factors that are found only in vertebrates
and regulate essential functions such as organismal development and reproduction, while also impacting aging,
tumorigenesis, and cancer progression. Small lipophilic hormones bind to steroid receptors for estrogens (ER-
alpha and ER-beta), progesterone (PR), glucocorticoids (GR), and androgens (AR) and transmit their signal
through gene regulation. Since these small molecules can be synthetically modified and manufactured, a variety
of pharmaceutical drugs provide critical medicines for diseases including metabolic disorders, reproduction, and
cancer treatment. NR mechanism of action has been mostly studied at RNA polymerase II (Pol II) transcribed
genes including protein-coding mRNAs and small/long non-coding RNAs. Multiple NRs act in complexes on DNA
to activate or repress Pol II transcription. However, NR controlled cell transcriptomes are often not always tightly
correlated with the proteome due to post-transcriptional regulation that is not completely understood. We have
uncovered a second layer of coordinated NR activity through regulation of RNA Polymerase III (Pol III)
transcribed genes. Pol III transcribes small RNAs essential for translation of mRNAs into protein including tRNAs
and 5S rRNA and is a major node for controlling cell growth, stem cells, aging, and cancer. Negative regulation
of Pol III is commonly through the conserved repressor Maf1. Very little is known concerning how NRs regulate
Pol III in more complex mammalian cells and organisms. We discovered using genome-wide analyses of PR
chromatin binding in ER+PR+ breast cancer cell lines and tumors that PR localizes at multiple tRNA genes. PR
associates with the Pol III complex and decreases tRNA levels and protein synthesis. Progesterone recruits PR
and retinoic acid receptor alpha (RARα) to tRNA genes near a conserved DNA sequence resembling an NR
binding half site. Our hypothesis is that PR regulates Pol III transcription of tRNA genes through crosstalk with
RARα and recruitment of Maf1 resulting in decreased levels of target tRNA genes and selective translation. Aim
1 will determine how PR associates at tRNA genes, the role of RARα and other steroid receptors, and the NR
binding half site. Aim 2 will determine the role of Maf1 in PR modulation of Pol III transcription. Aim 3 will define
hormone-induced changes in the tRNA pool and the impact on translational efficiency. Regulation of Pol III is
vastly understudied compared to Pol II and crucial for normal and oncogenic cell phenotypes. Results of this
study will define a novel mechanism of NR action at Pol III genes that will help explain i) an additional layer of
hormone regulation that contributes to selective mRNA translation, and ii) how NRs converge on multiple cell
polymerases to impact cell growth, differentiation, stemness, and tumor progression.

Public health relevance
Project narrative RNA polymerase III (Pol III) transcribes transfer RNA (tRNA) genes essential for protein synthesis and cell growth and thus has increased activity in cancer. However, regulation of Pol III remains poorly understood in mammalian cells and cancers. This proposal studies how cell permeable hormones including progesterone and retinoic acid activate their cognate nuclear receptor transcription factors to directly regulate Pol III and alter the tRNA pool in breast cancer cells. This work will define an additional layer of coordinated nuclear receptor gene regulation that contributes to the frequent non-linear translation of messenger RNAs into protein that impacts cell growth, stemness, and cancer.